Eliciting Cardiomyocyte Proliferation by Un-blocking Mitotic Transit

PROJECT SUMMARY
Adult ischemic heart injury causes significant loss of cardiomyocytes (CMs) which, over time, leads to
heart failure. Developing methods to therapeutically stimulate cardiomyogenesis promises to improve the lives
and survival of these patients. However, cardiomyogenesis in the adult mammalian heart is challenging due to
the limited proliferative capacity of adult CMs. Cardiomyocyte proliferation, as determined by complete cell
division and daughter cell generation, occurs during embryogenesis and early postnatal maturation, and requires
the CMs to enter the cell cycle and progress through mitosis. However, during postnatal maturation, despite
active entrance into the cell cycle, mitosis is either bypassed or aborted, termed endoreplication, leading to
polyploidy and failure to expand CM numbers. Thus, upon ischemic injury, the mouse heart is regenerative within
the first postnatal week via proliferation of pre-existing CMs but becomes non-regenerative after the first
postnatal week due to incomplete CM division. The process and regulators that decide division versus
endoreplication in CMs are poorly understood. Their elucidation is essential to achieve successful heart
regeneration. Thus, our overarching goal is to elucidate molecular and cellular mechanisms that regulate CM
mitosis as a means to ultimately achieve cardiac regeneration after ischemic injury.
To prepare for and progress through mitosis, cells undergo an extensive reorganization of cytoskeleton
to accurately guide chromosome segregation and give rise to daughter cells. We have discovered that Lmnb2,
which encodes the nuclear lamina protein Lamin B2, functions as a novel mitotic regulator, which becomes
significantly repressed during the transition of postnatal CMs to the non-regenerative state. Our preliminary data
showed that depletion of Lamin B2 blocks CM division and activates endoreplication by inhibiting reorganization
of the mitotic cytoskeleton. However, the regulatory mechanisms of Lamin B2 function in controlling the switch
from division to endoreplication during postnatal development remain elusive. Our recent work suggests that
Lmnb2 inhibition, and therefore the switch to endoreplication is regulated by the transcriptional repressors, E2F7
and E2F8. We hypothesize that repression of Lmnb2 by E2F7/8 prevents completion of mitosis in non-
regenerative CMs by inhibiting reorganization of the mitotic apparatus in cycling CMs, and therefore gain
of Lmnb2 function will promote mitotic division resulting in proliferation and heart regeneration after
ischemic injury. We propose two Specific Aims. Aim 1 will elucidate the mechanisms of mitotic cytoskeletal
reorganization that are mediated by Lamin B2, and its effect on adult heart regeneration after ischemic injury.
Aim 2 will assess the impact of CM-specific depletion of E2F7/8 on Lmnb2 expression and CM proliferation in
the ischemic adult heart. Our incomplete understanding of how CM division is repressed in postnatal CMs
constitutes an enormous obstacle to designing heart regeneration strategies. This research will help elucidate
the mechanistic basis of mitotic regulation at key developmental stages, and after cardiac injury.

Public health relevance
PROJECT NARRATIVE This proposal is rooted in the fundamental cell biology underlying heart muscle cell division and expansion during heart development, as well as its impact on ischemic heart repair. We will investigate the cellular mechanisms and their components that direct the organization of the mitotic apparatus, a requirement for heart muscle cell division, and how they affect remuscularization post ischemic heart injury. The current incomplete understanding of how division is repressed in adult mammalian cardiomyocytes constitutes an enormous obstacle for designing heart regeneration strategies, and this research will help to elucidate the mechanistic basis of mitotic regulation at key developmental stages, and after cardiac injury.